PAIN PERCEPTION AND HEALTH CARE SEEKING BEHAVIOR IN FIBROMYALGIA

The overall goal of the proposed project is to better understand the pain and psychosocial factors that may be associated with status as a patient or non-patient among persons with fibromyalgia (FM). To accomplish this goal, the proposed project will use longitudinal as well as cross-sectional comparisons of pain perception and psychosocial variables among three subject groups. These three groups are: a) patients drawn from the UAB Rheumatology Clinic who have sought medical treatment for FM; b) age-, education-, and gender-matched persons sampled from the Birmingham community who meet the criteria for FM but who have not sought medical care for their symmptoms (i.e., FM non- patients); and c) age-, education-, and gender-matched healthy controls sampled from the Birmingham community.